APC SPECIFIC MTOP INHIBITION POTENTIATES IMMUNE RESPONSE TO IIV IN ELDERLY RECIPIENTS.

The contract supports the development of a vaccine adjuvant. The adjuvant development activities will occur within the context of an influenza vaccine.